RNA regulation associated with mcr11-abmR locus in M. tuberculosis

Project summary
Mycobacterium tuberculosis (Mtb) adapts to host-associated environments during infection by
modulating gene expression. While transcription factors (TFs) are the most widely recognized
regulators of bacterial gene expression, RNA-based factors that modulate gene expression in
Mtb are less well understood. The long term goal of this project is to define fundamental
mechanisms of gene regulation in Mtb, with a particular focus on the role of RNAs. The
objective of this project is to define riboregulatory mechanisms associated with two products of
the abmR-mcr11 gene locus in Mtb: the prototypical sRNA Mcr11 and the dual function RNA
binding TF AbmR, which is required for stable mcr11 expression. We will test the hypothesis
that multiple distinct regions of Mcr11 regulate gene expression by base pairing with target
mRNA sequences, and characterize the impact of Mcr11 regulation in Mtb. Stable expression of
Mcr11 requires AbmR, which binds ATP and contributes to central metabolism in Mtb by
repressing expression of the menaquinone biosynthesis gene menE. We propose that RNA-
mediated oligomerization of AbmR reduces its TF activity by converting it to a 39S complex with
an alternate function. High resolution structural information regarding the nature of the RNA-
AbmR complex interaction is critically needed to identify AbmR complex functions and its
possible roles in Mtb biology. The specific aims of this research include: Aim 1: Define
regulatory interactions of Mcr11 at the biological, molecular and genetic levels; and Aim 2:
Characterize the roles of RNA-AbmR interactions at the structural and biochemical levels.
These studies will combine high resolution cryo-electron microscopy with strategic mutagenesis,
biochemical and biological approaches to define AbmR-RNA interactions while providing
fundamental new insights into RNA-mediated regulatory mechanisms in Mtb.

Public health relevance
PROJECT NARRATIVE Tuberculosis (TB) is a major global health problem, and better understanding of its biology is urgently needed to reduce its deadly impact. M. tuberculosis (Mtb) uses gene regulation to respond to changing environments as part of its survival strategy within the host, and this regulation can be mediated at multiple levels. This work will characterize RNA-based regulatory mechanisms and their relationship to a novel dual function regulatory protein in Mtb.